Novel PET Radiotracer for Muscarinic M1 Receptor

The acetylcholine neurotransmitter system plays an important role in the maintenance of normal physiology such as memory function, and its dysregulation/dysfunction has been implicated in a variety of neurological and psychiatric disease, especially in cognitive impairments associated with Alzheimer’s disease (AD) and schizophrenia. The muscarinic acetylcholine receptors (mAChRs) are important targets for drug development in AD and schizophrenia. Agonists at the orthosteric or allosteric sites of the M1 subtype receptor are currently under development as drugs for the treatment of cognitive deficits. Positron Emission Tomography (PET) is a non-­invasive imaging technique that allows the in vivo investigation of neuroreceptors in the living body and in receptor occupancy studies of emerging drugs. The availability of PET imaging agents selective for the M1 AChR will provide a non-­invasive biomarker to interrogate this receptor subtype in vivo in humans and gain insights into its function and dysfunction in diseases. Further, PET imaging with an M1 AChR selective radiotracer can be used as an in vivo biomarker to assess target engagement and correlate target occupancy, dose exposure and therapeutic response of emerging M1 AChR-­targeting drugs in clinical trials, thus aiding the development of novel therapeutic agents. There have been no prior reports of validated, selective PET radiotracers for use in humans to image M1 AChR. We are the first to carry out the radiosynthesis of a selective M1 AChR radiotracer, 11C-­EMO, and evaluated it in non-­human primates. Further we have performed preliminary characterization of this novel PET radiotracer in humans and demonstrated its usefulness to image and quantify M1 AChR availability in the brain. In this application, we propose to fully validate 11C-­EMO for the imaging and quantification of M1 AChR in humans and for detection of changes in synaptic acetylcholine concentrations. Our ultimate goal is to provide the biomedical imaging community with an optimal, selective PET radiotracer for in vivo imaging of M1 AChR in humans. The development and successful deployment of a suitable PET imaging agent for M1 AChR will enable, for the first time, the in vivo investigation of this receptor subtype in psychiatric and neurological diseases, and drug occupancy studies of emerging M1 AChR targeting therapeutic agents.

Public health relevance
This project proposes to develop a positron emission tomography (PET) agent for imaging the M1 subtype of muscarinic acetylcholine receptors (AChR) in humans. Availability of a suitable PET imaging agent for M1 AChR will provide the biomedical research community with a non-invasive, quantitative method to investigate the expression and functionality of this receptor subtype in the brain, as well as its possible dysfunction in patients with schizophrenia and Alzheimer's disease. Its application in receptor occupancy studies will also assist in the development of new drugs targeting the M1 AChR for treatment of cognitive impairments associated with these diseases.